Genomic and Developmental Mechanisms of SIX2-Related Frontonasal Dysplasia

Abstract
On average, a human genome harbors ~27,000 structural variations (SVs), including deletions,
duplications, and other genomic changes over 50 bp in size, which contribute significantly to phenotypic
variations. Recent studies have shown that SVs can disrupt local genome organization known as topologically
associating domains (TADs), resulting in misexpression of neighboring genes and causing developmental
disorders and other diseases. In this project, we study genomic disruptions associated with frontonasal
dysplasia (FND), a congenital craniofacial disorder that profoundly affects the structure and function of the
orofacial complex, as a model for understanding genome organization and molecular mechanisms underlying
craniofacial development and malformations. Several independent studies have associated FND with partly
overlapping heterozygous microdeletions at Chromosome 2p21 in which SIX2 is the only protein-coding gene.
SIX2 is a member of the SIX- and homeo-domain containing DNA-binding transcription factors. In all
vertebrate genomes, Six2 is physically linked to Six3 in a tail-to-tail configuration, with these two genes
organized into separate TADs flanking a conserved TAD boundary. Six2, but not Six3, is abundantly
expressed in the cranial neural crest cell (CNCC) derived frontonasal mesenchyme and in nephrogenic
mesenchyme during mouse embryogenesis. Whereas Six2+/- mice are phenotypically normal and Six2-/- mice
exhibit kidney hypoplasia with normal frontonasal structures, our preliminary study found that deleting Six2
together with part of the Six2/Six3 intergenic region, but not including the Six3 gene or Six2 distal enhancers,
caused midline facial clefting in heterozygous mice. On the other hand, mice carrying a heterozygous deletion
including Six2, Six3, and their intergenic region in between, could survive with no frontonasal defects. We
hypothesize that SIX2-related FND is caused by gain of SIX3 expression in developing frontonasal
mesenchyme due to TAD boundary disruption and enhancer adoption rather than by SIX2 haploinsufficiency
as previously believed. This project will test this novel hypothesis and unravel the genomic and molecular
developmental mechanisms underlying SIX2-related FND. Data from these studies will provide novel insights
into mechanisms of craniofacial development and functional divergence of the SIX family transcription factors,
and lead to improvements in molecular diagnosis, medical assessment and interpretation of clinical genomics
data, and treatment/care of SV-associated developmental disorders.

Public health relevance
Narrative Using mouse models carrying specific regional genomic changes associated with congenital human craniofacial disorders, this project will gain new understanding of genome structure and function crucial for craniofacial development. The new findings will lead to improvement in clinical diagnosis, medial assessment, genetic counseling, and treatment of patients with craniofacial and other developmental disorders.